Functional Biology Of T Cells

White blood cells called T lymphocytes play critical roles in immune defense against viruses, bacteria, fungi, protozoa, and cancer cells. In the unactivated state, these cells circulate in the blood and accumulate in lymphoid tissues such as lymph nodes and spleen. Upon encounter with foreign materials (antigens) on the membranes of specialized antigen presenting cells (dendritic cells), these resting T-cells become activated, undergo numerous cell divisions, and differentiate into effector cells. The effector cells leave the lymphoid tissues and blood, entering sites of infection to combat pathogens. They can also invade normal tissues where their activity can cause autoimmune pathology. After elimination of an infecting organism, most of the activated T-cells die, but some remain as memory cells, to provide a more rapid and vigorous response if the same pathogen is encountered in the future. Recent work has suggested that this general scheme applies to both CD4+ and CD8+ T-cells, but that there are also important differences in the signals that control the extent of proliferation and the survival of memory cells for these two T-cells lineages. Furthermore, there are also data suggesting that memory cells may be of more than one type, with some recirculating in lymphoid compartments and others patrolling peripheral tissues. The former may provide the major source of new cells upon re-infection, whereas the latter may mediate the earliest effector response to the infection. The proper balance of both types may be critical for effective T-cell mediated host defense. This project attempts to gain a quantitative understanding of the activation, differentiation, migration, memory status, and reactivation properties of both CD4+ and CD8+ T-cells. Issues such as the route, amount, and frequency of antigen exposure, as well as the presence or absence of adjuvants that stimulate the innate immune system, will be studied for their effects on the generation and tissue distribution of effector and memory CD4+ and CD8+ T-cells. The movement of activated T-cells into non-lymphoid tissues will be analyzed. Through this research, a better understanding of lymphocyte dynamics during an immune response to infection or after vaccination will be established. .These new insights can contribute to the more effective design of vaccines and to strategies for the amelioration of autoimmune processes.